Immunometabolic pathways enabled by PARP inhibition in breast cancer

PROJECT SUMMARY
Tumor associated macrophages (TAMs) are abundant in solid tumors and drive tumorigenesis and resistance
to therapy. Strikingly, a commonly used cancer drug, poly (ADP-ribose) polymerase inhibitors (PARPi), drive
development of suppressive TAMs through metabolic remodeling and induction of lipogenesis that restrict T-
cell activation and function. Conversely, T-cells treated with PARPi exhibit bioenergetic fitness, superior viabil-
ity, and heightened effector function. While there is enthusiasm for combining PARPi with immune checkpoint
blockade (ICB), based on potential synergy of T-cell activation of each class of drug, early phase clinical trials
have not yet demonstrated the combination to be superior to PARPi monotherapy, suggesting lipogenic TAMs
may limit PARPi + ICB responses. Thus, there is a critical need to elucidate the dichotomy of PARPi-induced
metabolic remodeling to generate deleterious TAMs while promoting superior antitumor T-cells. In the absence
of such knowledge successful strategies to harness the power of PARPi to benefit cancer patients are unlikely.
The long-term goal is to design clinically effective strategies through TAM modulation to promote T-cell activa-
tion and weaken the immune-suppressive TME to improve therapy in breast cancer patients. The central hy-
pothesis is that lipogenic TAMs promote tumorigenesis in part through T-cell inhibition and are catalyzed by
PARPi therapy, offering a unique therapeutic opportunity to enhance PARPi + ICB. The overall objectives are
to (i) characterize TAM and T-cell metabolic regulation during PARPi and (ii) determine clinically effective strat-
egies to regulate TAM metabolism to enhance T-cell activation and PARPi responses. The central hypothesis
will be tested by pursing the following specific aims: 1) Define the mechanism of lipogenic macrophage de-
velopment. Human and murine monocytes and macrophages will be used to formally define TAM lipogenesis
catalyzed by PARPi and determine the mechanism by which TAM lipogenesis is induced during TNBC therapy
using unbiased lipidomic as well as functional studies. 2) Test that lipogenic TAMs promote tumorigenesis
through suppression of PARPi-mediated metabolic remodeling of adaptive immunity. Aim 2 will employ
in vitro and in vivo protein synthesis, proteomics and metabolomic analysis to detail how PARPi induces T-cell
metabolic fitness and define optimal metabolic perturbation for anti-tumor therapy. 3) Determine the optimal
treatment strategy of PARPi and metabolic remodeling for rapid translation to breast cancer patients.
Multiple TNBC mouse models will be employed to test if depletion of TAMs clears a path for T-cells with im-
proved bioenergetic fitness fashioned by PARPi, metabolic remodeling, or the therapies combined. Unique
clinical trial samples from patients treated with PARPi and PARPi + ICB will be assessed using state-of-the-art,
single cell imaging to identify immune phenotype and function. Successful completion will reveal novel thera-
peutic strategies to circumvent lipogenic TAMs while simultaneously activating metabolically superior antitumor
T-cells and has potential for rapid clinical translation to increase the effectiveness of PARPi + ICB therapy.

Public health relevance
PROJECT NARRATIVE Tumor associated macrophages (TAMs) are highly suppressive in the tumor microenvironment (TME) and contribute to chemo- and immuno-therapy resistance. Our lab has made the discovery that a commonly used cancer therapy, PARP inhibitors (PARPi), induce lipogenic metabolism in TAMs rendering them even more suppressive, in which they inhibit T-cell function and activation, and limit therapeutic responses; importantly, however, in the absence of TAMs, PARPi promotes metabolically superior T-cell antitumor traits. Our proposal will formally determine how lipogenic TAM and T-cell metabolism is regulated during PARPi therapy, which is likely to provide opportunities for the development of novel treatment strategies that hold the power to overcome the immune-suppressive TME and improve PARPi therapy success in a number of cancer types.